Module 3: Gene Expression/Proteomics

The gene expression and proteomics module will provide investigators with expertise in designing and
performing studies of global gene expression profiles and proteomic alterations related to diseases of the visual
system. In the last two decades, a number of high throughput platforms have been developed to investigate
global gene expression patterns. These technologies include spotted cDNA or oligonucleotide arrays, Affymetrix
GeneChip microarrays, Illumina BeadChip microarrays, and most recently next-generation sequencing
technologies including RNA sequencing (RNA-Seq) and Single-cell RNA sequencing (scRNA-seq). This Core
will use RNA-Seq and scRNA-seq for gene expression studies. Similarly, the development of Liquid-
Chromatography Mass Spectrometry (LC-MS/MS) over the last decade has revolutionized proteomic analyses
through its unprecedented depth, speed and accuracy even with small volume samples. One of the latest
breakthroughs in this technology is the Orbitrap Fusion Tribrid mass spectrometer, which allows researchers to
extend the limits of proteomic analyses including post-translational modifications. We have this instrument at
Augusta University and recently, we have successfully established a protocol for the analysis of the aqueous
humor proteome using this device. These latest sequencing and mass-spec technologies, used to evaluate gene
expression and protein levels, can be intimidating to researchers, whose scientific expertise lies elsewhere. The
new technologies also present challenges associated with high throughput data analyses and interpretation. To
circumvent these hurdles, the gene expression and proteomics module is intended to guide researchers in
experimental design, sample preparation, thoughtful selection of appropriate technology, and bioinformatics
support for sequencing and proteomic profiling. In addition, the core will also help researchers with the
interpretation of results and designing further experiments for confirmation/validation of findings. The goal of
this module is to guide vision researchers with high throughput gene expression analyses (using sequencing)
and proteomic analyses (using mass-spectrometry) of ocular tissues. The services offered in this module reflect
keen awareness of the nuances related to experimentation with specialized ocular tissues and will be
accomplished in two aims. Aim 1: Provide core investigators with expert consultation, tailored to analysis of the
visual system, on experimental design, sample preparation and selection of technology to conduct gene
expression studies and/or proteomic analyses of ocular tissues. Aim 2: Provide core investigators with excellent
bioinformatics support in analyzing the large data sets that are generated following high throughput gene
expression or proteomic analyses of ocular tissues.